Modular Synthesis of Saturated, Nitrogen-Containing Heterocycles Guided by Mechanism-Aware Machine Learning Models

1 PROJECT SUMMARY
2 Successful development of new active pharmaceutical ingredients (APIs) requires synthesizing many
3 structurally related compounds to optimize pharmacokinetic properties related to absorption, distribution,
4 metabolism, excretion, and toxicology. However, the expense of time and resources needed to synthesize each
5 candidate makes API optimization a bottleneck. As a result, researchers have developed a relatively short list of
6 expedient synthetic methods on which they rely to develop APIs. These methods tend to involve fragment
7 couplings that forge new C-C, C-N, or C-O bonds by joining two building blocks, which allows those seeking new
8 APIs to purchase libraries of suitable building blocks and explore their pairwise couplings in modular fashion.
9 The modularity of this approach means that each new fragment increases the quantity of structures that can be
10 explored in a nonlinear fashion. However, some of the most frequent substructures in APIs—saturated medium-
11 sized nitrogen-containing heterocycles—are not well represented in commercial catalogues of building blocks,
12 due to limitations in state-of-the-art synthetic methods used to produce them. The ability to create custom building
13 blocks in a modular fashion, which would enable both more thorough and more efficient structure optimizations
14 of APIs, would represent a significant advance in modern synthetic chemistry. However, current synthetic
15 limitations make exploration of 3D structural variants of these heterocycles difficult.
16 This proposal outlines a strategy to develop new catalytic methods that will convert readily accessible starting
17 materials into structurally complex heterocyclic building blocks in modular fashion. The modularity of the
18 proposed methods, the accessibility of starting materials, and the proposed catalyst control of stereochemistry
19 in these chiral products will make exploration of new, chiral variants of these important building blocks more
20 practical. The proposed research includes a tandem fragment coupling-cyclization approach to assemble
21 multiple building blocks to construct structurally complex, medium-sized, saturated heterocycles. Mechanistic
22 experiments and computational exploration of key mechanistic steps is proposed so that both activity and
23 selectivity of the catalysts can be understood and iteratively improved with the assistance of new data
24 representations and machine learning. Accomplishing these goals would provide practitioners access to diverse
25 structural variants of important building blocks for API development, as well as demonstrate the future role of
26 machine learning as a tool that can accelerate the development of methods with a large scope.

Public health relevance
PROJECT NARRATIVE The rapid development of new treatments for human diseases relies on synthetic chemists to create thousands of new structures to test to develop just one treatment. As a result, drug development is subject to the limitations of current synthetic methods. This proposal focuses on improving the efficiency with which practitioners can access a diverse array of pharmaceutically relevant, nitrogen-containing, saturated heterocyclic building blocks by developing chemical reactions that access such structures using multiple components.